EMERGE: Ecological Momentary Evaluation of Responses to Gain/Loss and Emotions

PROJECT SUMMARY/ABSTRACT
Suicide is a leading cause of death worldwide, accounting for nearly 800,000 deaths each year.1,2
Suicide rates continue to increase in the U.S.3 Patients seen in the emergency department are at elevated risk
of death4 and future suicidal behaviors.5 Most research on suicide risk factors has identified static, dispositional
factors.4 For instance, distal predictors of who is at risk for suicidal behaviors include dysfunctional emotional
responses1 and decision-making deficits.2 These data inform us about groups at elevated suicide risk, but do
very little to predict with useful precision when people will have suicidal thoughts or act on suicide thoughts.
Thus, there is an urgent need to identify proximal risk factors for suicide risk.
The Parent Study, “EMERGE: Ecological Momentary Evaluation of Responses to Gain/Loss and Emotions”
(R01MH128546), addresses this question with ecological momentary assessment (EMA) of emotions and
reinforcement learning as predictors of near-term suicidal thoughts and behaviors in 170 emergency department
patients seen for a suicide-related complaint. Yet emergency department patients are disproportionately low
income7 and minoritized,8 and many are unstably housed.9 This population is therefore simultaneously critical to
consider in suicide research and difficult to retain in research studies, as evidenced by high attrition from
enrollment to our initial assessment period. This supplement application is intended to address these challenges
that have the potential to compromise our efforts to (1) collect adequate data to allow for an examination of our
primary aims with sufficient power, (2) manage risk without undermining data validity, and (3) understand barriers
to implementing future clinical interventions based on our results. Specifically, Aim 1 increases the sample size
of enrolled participants to overenroll to 210 and increase monetary incentives to allow for adequately powered
analyses. Aim 2 evaluates participants’ experiences of the risk assessment protocols and their impact on data
validity via additional survey and interview methods. Aim 3 identifies barriers and facilitators of accessing
psychiatric care in this population via additional survey and interview methods.
To date, our research team has shown the ability to enroll participants on target and conduct this study safely.
This supplement will leverage this study of a particularly vulnerable population and allow us to make substantial
inroads in improving our suicide research and care.

Public health relevance
PROJECT NARRATIVE Suicide research has faltered in identifying short-term predictors of suicide risk and studies such as the parent study face unique challenges in the need to overrecruit from a population that faces unique adversities (e.g., suicidal crises, low resources, and housing instabilities). The proposed supplement seeks to leverage the research to identify suicide risk markers in this vulnerable population by (1) improving our power to detect effects, (2) improving suicide research by identifying how suicidologists can effectively manage risk, and (3) addressing early implementation considerations for how we can best provide suicide prevention and care to vulnerable populations. NIH’s mission will be served by the proposed supplement through improving the prediction of suicidal behaviors in high-risk populations, improving future suicide research, and informing prevention efforts, ultimately reducing suffering and mortality with substantial societal cost.